PREDOCTORAL FELLOWSHIP PROGRAM (DISABILITY)

This research, in the form of dissertation, will focus on the concepts of stigma and information control by those considered deviant within society. The inquiry itself will take two forms: one, narratives of those suffering from chronic illness and narratives of gay men will be gathered and analyzed using qualitative sociological research methods; secondly, an analysis and historical record of information control among deviant populations, specifically the chronically ill, will be analyzed and developed.